Structure and Mechanism of G-proteins and cell adhesion proteins in regulation of cell growth and motility

Abstract
The presented project is a comprehensive investigation encompassing two primary themes. The
first theme revolves around the exploration of novel mechanisms governing the activation and
signaling of guanine nucleotide-binding (G)-proteins, with a particular focus on the RAS
superfamily and heterotrimeric Gα-proteins. Departing from conventional beliefs that G-protein
activity is predominantly influenced by nucleotide cycling, recent findings challenge this
paradigm. The project aims to delve into the regulation of inactive 'off' and active 'on' states of
Gα-proteins by scrutinizing key allosteric networks within the Switch regions. Research
objectives include elucidating interactions within the allosteric Switch network, investigating
novel mechanisms controlling G-protein activation through pH modulation, and exploring the
overlooked role of RAS-related proteins in mediating lipid kinase regulation. Employing a
multidisciplinary approach that integrates computational, structural, biochemical, and cell
biology methodologies, the project seeks to advance our understanding of G-protein regulation,
contributing valuable insights for precision medicine strategies targeting G-protein-mediated
pathologies. The second theme of the project centers on cell adhesion proteins, vinculin, and
metavinculin. The investigation aims to unravel the individual and coordinated roles of these
isoforms in regulating cell morphology, force transmission, and cell motility. Additionally, the
project seeks to elucidate how metavinculin mutations, implicated in heart defects, disrupt
adhesion site morphology and contractile force. Building on prior research into vinculin catch
bonds with filamentous actin, the project expands molecular and functional studies to
comprehend the collaborative roles of vinculin, metavinculin, and α-catenin in the directional
and force-dependent regulation of adhesion morphology, force transmission, directed migration,
and mechanosensitive diseases resulting from dysregulated mechanical cues. This dual-themed
project employs a holistic and integrative approach, fostering a deeper understanding of cellular
processes and providing a foundation for potential therapeutic interventions in diseases
associated with G-protein and cell adhesion protein dysregulation.

Public health relevance
Narrative We propose highly integrated multidisciplinary studies to unravel novel mechanisms governing the recognition, activity regulation and cell signaling of monomeric and heterotrimeric G- proteins. Our research efforts extend to cell adhesion proteins, including vinculin and metavinculin, revealing their individual and coordinate roles in modulating actin cytoskeletal rearrangements to shape cell morphology, facilitate force transmission, and regulate cell motility. By unraveling the complexities of cell signaling and adhesion processes, our findings may pave the way for more effective and targeted therapeutic interventions and improve outcomes for individuals affected by a wide range of disorders, including cancer and cardiovascular disease.